Molecular and Cellular Immunobiology

Project Summary/Abstract
We seek renewal of a long-standing training program in Cellular and Molecular Immunobiology to
continue cutting-edge predoctoral training leading to the PhD in Immunology. This training grant
previously supported both predoctoral and postdoctoral trainees but in this renewal application we
request support for 10 predoctoral trainees in accordance with recent NIAID guidelines on the cap for
training slots. The training program features research training in the laboratories of Stanford
immunologists whose interests span basic, computational, translational and clinical immunology. Other
pillars of the predoctoral training program include coursework that emphasizes critical thinking and
analysis of current problems in immunology, seminars by leading immunologists from around the country,
teaching opportunities in undergraduate and graduate courses, and training in the written and oral
communication of science and the responsible conduct of research. Predoctoral trainees come from an
outstanding, diverse pool of applicants with strong academic and research credentials. Individualized
advising and mentorship are emphasized, with a flexible approach and a curriculum tailored to enhance
the preparation and success of each student. Trainees benefit from a stimulating and nurturing training
environment and can choose from one of two curriculum tracks: Molecular, Cellular and Translational
Immunology which constitutes the traditional track, and the Computational and Systems Immunology
track which combines training in immunology with computational and systems methodologies. The
innovative, interdisciplinary program brings together a distinguished faculty from 19 basic and clinical
departments across the medical school and university, and is supported by world-class resources and
facilities. The success of this training program is evidenced by the outstanding publication record of our
trainees, their ongoing contributions to the field of Immunology, and their achievements as leaders in
their chosen careers.

Public health relevance
Project Narrative The goal of the Molecular and Cellular Immunobiology training program is to attract a diverse and talented group of predoctoral students and provide them with cutting-edge training leading to a PhD in Immunology. The field of Immunology is increasingly recognized as important in a broad range of human diseases. A cadre of well- trained, innovative young Immunologists is essential to achieve a basic understanding of the immune system, and to successfully develop new diagnostics and therapies for immune-related diseases.